Support for Biomedical and Clinical Information Services for the National Library of Medicine and Other NIH Institutes and Centers

Support for Biomedical and Clinical Information Services for the National Library of Medicine and Other NIH Institutes and Centers